Regulation of ESCRT-III activity in yeast

PROJECT SUMMARY
Membrane scission by the ESCRT-III complex is a highly conserved cellular mechanism required for protein
degradation in lysosomes as well as other cellular processes. ESCRT-III membrane scission activity has best
been defined in the context of in vitro reconstitution assays, but the mechanisms that operate in vivo to control
the activity of ESCRT-III under physiological conditions are poorly understood. The long-term goal of this
project is to understand the mechanisms of membrane trafficking in the endocytic pathway. The objective of
this application is to use the budding yeast Saccharomyces cerevisiae as a model system to identify mecha-
nisms that regulate ESCRT-III at endosomes The central hypothesis of the project is that membrane scission
by ESCRT-III is negatively regulated by the deubiquitination machinery at endosomes. The rationale for the
proposed research is that, once it is known how ESCRT-III membrane scission activity is regulated, this
process can likely be manipulated pharmacologically, paving the way toward new and innovative approaches
in the prevention and treatment of genetic and infectious diseases linked to ESCRT-III.. The specific aims of
the project are to determine the mechanism by which ESCRT-III is regulated by Doa4 and to define the mech-
anism that relieves Doa4 from inhibition. Doa4 is a ubiquitin hydrolase that deubiquitinates transmembrane
protein cargoes sorted into ILVs; but Doa4 also functions non-enzymatically in ILV membrane scission by regu-
lating ESCRT-III complex stability. The working hypotheses that guide each specific aim of the project are that
Doa4 inhibits disassembly of ESCRT-III complexes and that Doa4 is relieved from its inhibitory binding by
Bro1, which is a Doa4 cofactor. The methodology to be used in the project includes electron microscopy, light
microscopy, protein biochemistry, and functional assays. The contribution of the proposed research is expect-
ed to be the determination of regulatory mechanisms that control ESCRT-III activity; given the high degree of
conservation in ESCRT-III function, it is expected that the results from this project will also yield insight into
how ESCRT-III activity is controlled in human cells. This contribution is significant because defining these reg-
ulatory mechanisms in vivo is crucial for understanding how ESCRT-III activity is controlled under normal phys-
iological conditions and how it is vulnerable in disease states.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because dysfunction of the ESCRT-III complex has been linked to neurodegenerative disease, and its exploitation is essential for the spread of HIV-1 and other retro- viruses. The ESCRT-III complex mediates membrane scission at multiple intracellular sites using an evolu- tionarily conserved mechanism of function. Therefore, the proposed research is relevant to the mission of NIGMS in understanding biological processes as a foundation for advances in disease diagnosis, treatment, and prevention.